Preventing Weight Gain and Diabetes in People with HIV in South Africa

PROJECT SUMMARY
Background: Obesity and diabetes are important risk factors for morbidity and mortality in people with HIV
(PWH), especially in sub-Saharan Africa where health systems are already grappling with a rapid rise in
metabolic disease. Dolutegravir (DTG)-based antiretroviral therapy (ART) has recently been adopted as the
first-line regimen in most of the region, despite evidence that it is associated with excess weight gain. While the
HIV care system offers a capable health systems platform, obesity and diabetes prevention is not a current
focus of care paradigms. Candidate: I am a Clinical Fellow in Infectious Diseases at Massachusetts General
Hospital and a physician-scientist with doctoral-level training in global health epidemiology and a strong track
record of published observational research. However, my recent experiences caring for PWH have led to a
desire to gain new skills in the design and execution of interventional trials to prevent metabolic disease in this
population. My overarching career goal is to become an independent, NIH-funded physician-scientist with
expertise in the metabolic complications of treated HIV, and in developing and testing clinical interventions to
prevent these complications. Training: To achieve research independence, I will require additional training in
1) obesity medicine and diabetes prevention, 2) behavioral model-based intervention design, and 3) the
conduct and analysis of clinical trials to prevent metabolic complications of HIV. Mentors: My training and
research plans will be overseen by my primary mentor Dr. Mark Siedner, who has extensive mentoring
experience and conducts both observational cohort studies and clinical trials in South Africa. Drs. Janet Lo
(obesity medicine and diabetes prevention), Christina Psaros (behavioral model-based intervention design),
and Deborah Wexler (the conduct and analysis of clinical trials) will serve as co-mentors to provide additional
focused expertise. I will also receive annual feedback from my Scientific Advisory Board, which includes Drs.
Rochelle Walensky, Naomi Levitt, Robert Parker, and Till Bärnighausen. Research: With guidance from my
team of mentors, I will explore the metabolic effects of DTG among PWH in South Africa and develop and pilot
an intervention to mitigate these complications through three specific aims: 1) To determine the behavioral
correlates of weight change and glucose intolerance for PWH transitioning to DTG-based ART in South Africa;
2) To develop an acceptable and contextually appropriate intervention to prevent weight gain and diabetes in
PWH on DTG-based ART in South Africa; and 3) To conduct a factorial-randomized feasibility study of
interventions to prevent weight gain and diabetes among PWH on DTG-based ART versus usual care. We will
carry out this research through existing collaborations with the Wellcome Trust-funded Africa Health Research
Institute (AHRI). Through this period of training and research, I will be well positioned to achieve research
independence and plan to submit an NIH R01 application in the fourth year of this project to test the efficacy of
an intervention to prevent weight gain and diabetes in PWH in South Africa.

Public health relevance
PROJECT NARRATIVE HIV treatment programs throughout sub-Saharan Africa are adopting dolutegravir (DTG)-based regimens as first-line antiretroviral therapy (ART) despite early evidence that this agent is associated with excess weight gain. In this proposal, I will evaluate the behavioral correlates of weight change and glucose intolerance associated with DTG-based ART, apply these findings in developing contextually appropriate interventions to prevent weight gain and diabetes in people with HIV (PWH) and then assess these interventions in a factorial- randomized feasibility pilot study. This research is of high public health relevance given the widespread use of DTG globally, including up to 20 million PWH in sub-Saharan Africa, the background obesity epidemic in the region and the excellent platform offered by HIV treatment programs, through which interventions to prevent obesity can be delivered.